ANTIARRHYTHMIC AND HEMODYNAMIC EFFECT OF CIBENZOLINE

This is an on-going placebo-controlled single-blind prospective trial of patients with life-threatening tachycardia to be treated with placebo and Cibenzoline. This includes a hemodynamic protocol in the CRC.